Targeting macrophage persistence to prevent the AKI-to-CKD transition

Project Summary/Abstract
Acute kidney injury (AKI) significantly increases the risk of developing progressive kidney fibrosis and chronic
kidney disease (CKD). Macrophages play complex roles in AKI, with classically activated proinflammatory
macrophages initially serving for clearance of apoptotic cells and debris after injury, and alternatively activated
reparative macrophages promoting tubule repair followed by either egress or apoptosis of the macrophages in
the event of adaptive repair. However, persistent parenchymal inflammation or more severe injury leads to
maladaptive kidney repair. Our recent publication and preliminary data has shown that failure to achieve tubular
repair after unilateral ischemia/reperfusion injury (U-IRI) leads to abnormal intrarenal profibrotic macrophage and
dendritic cell accumulation beyond day 10. The expression of potential macrophage homing and profibrotic
activation signals in unrepaired kidneys reveals high-level expression of macrophage chemoattractant protein-1
(Mcp1), predominantly by macrophages, along with sustained expression of chitinase 3-like 1 (Chi3l1 or Brp39),
predominantly by endogenous renal cells. The cognate receptor for Mcp1, Ccr2, is highly expressed on all bone
marrow-derived cells; while the profibrotic receptor for Brp39, Crth2, is highly expressed on both macrophages
and myofibroblasts. We found that injured kidneys from Brp39-/- mice and Ccr2-/- mice exhibit less profibrotic
macrophage accumulation and interstitial fibrosis than wild-type control mice. Together, these findings have led
us to hypothesize that failed tubule repair following kidney injury promotes sustained tubular cell expression of
Brp39, with increased Crth2+ macrophage and myofibroblast profibrotic activation, and that the Brp39-stimulated
macrophages upregulate Mcp1, leading to further Ccr2-dependent proinflammatory cell accumulation,
myofibroblast activation, renal fibrosis and dysfunction. Thus, targeting the Brp39-Crth2 and/or Mcp1-Ccr2
signaling pathways after kidney injury holds great potential for the treatment of CKD progression. To test this
hypothesis, we propose to first define the role of macrophage-Mcp1 expression in promoting abnormal
accumulation and activation of Ccr2+ inflammatory cells in the setting of maladaptive kidney repair (Aim 1); and
then determine the importance of sustained tubular cell-Brp39 expression in the profibrotic activation of Crth2+
macrophages and myofibroblasts (Aim 2). Lastly, in order to translate our understanding of these two signaling
into the development of clinically relevant therapeutics, we will engineer and test two distinct dendrimer-based
nanomedicines for selective targeting of proximal tubule-Brp39 expression and of interstitial macrophage-Ccr2
and -Crth2 signaling responses to slow or prevent CKD progression (Aim 3). The studies and career
development/training activities in this K01 proposal are designed to equip Dr. Leyuan Xu with the technical and
scientific expertise and the experience to become an independent investigator exploring the topics of CKD and
its related translational medicine.

Public health relevance
Project Narrative Acute kidney injury (AKI) significantly increases the risk of developing progressive kidney fibrosis and chronic kidney disease (CKD). Macrophages play important roles in the AKI-to-CKD transition. This proposal will seek to (1) identify the signals that promote profibrotic macrophage accumulation and activation and (2) develop innovative translational nanomedicines that selectively target these signaling responses to slow or prevent CKD progression.